Gastrointestinal Insights into Anorexia Nervosa Treatment

This novel project aims to investigate the underexamined, biological mechanisms driving gastroparesis in
chronic anorexia nervosa (AN), a severe condition characterized by high morbidity and limited treatment
options. Gastroparesis, a condition where the stomach's ability to empty its contents is delayed, is highly
prevalent in individuals with chronic AN and may play a key role in perpetuating the disorder. The slowing
of gastric emptying contributes to a range of gastrointestinal (GI) symptoms, such as early satiety, nausea,
and bloating, which research has shown can heighten fear of eating and reinforce food restriction
behaviors. This creates a vicious cycle where AN cognitions and behaviors, along with physiological
dysfunction, feed into one another, making it harder to treat the disorder effectively. However, to date, no
study has thoroughly attempted to address how gastrointestinal dysfunction may play a role in the
maintenance of chronic AN. By focusing on interactions between glucagon-like peptide-1 (GLP-1), gut
microbiota dysbiosis, and gastric emptying, we aim to explore how these factors contribute to the
persistence of AN. Specifically, we hypothesize that slower gastric emptying correlates with increased selfreported
AN symptoms, with gastroparesis partially mediating this relationship. Additionally, we will
examine how GLP-1 responsiveness and gut microbial beta-diversity moderate the relationships between
gastric emptying, gastroparesis, and AN behaviors. Data will be collected from participants on an inpatient
eating disorder unit through laboratory assessments, including gastric emptying evaluations and GLP-1
response measurements, along with ecological momentary assessments (EMA) tracking symptoms over
two weeks. A second fecal sample and clinical information collected one month post-discharge will assess
changes in gut microbiota diversity and GI distress. By elucidating these mechanisms, this research has
the potential to inform novel treatments (i.e., emerging pharmacological interventions such as GLP-1
antagonists) that reduce the chronicity of AN and address the "crisis in care" for individuals with this
challenging disorder.